CTSA Predoctoral T32 at the Ohio State University

The goal of this new Ohio State University (OSU) Center for Clinical and Translational Science (CCTS) predoctoral training program is to leverage our large, collaborative, and multidisciplinary research environment to increase the reach of CTS education and training across the OSU campus and to recruit and develop an outstanding cohort of trainees to become the next generation of clinical and translational scientist leaders. This new program, built upon the foundation of 14 years of experience with the OSU CCTS TL1 program, aims to provide trainees with knowledge, skills and abilities that will expand the scope of their current and future research and prepare them to confidently communicate with various stakeholders and lead multidisciplinary research teams to drive biomedical and clinical innovations. We aim to foster a learning environment grounded in mentorship excellence through mentorship training, monitoring and constructive feedback. Post candidacy trainees are selected from a wide range of graduate programs in nine colleges including Health Sciences Colleges (Medicine, Optometry, Public Health, Pharmacy, Nursing, Dentistry, Veterinary Medicine), Engineering, Arts & Sciences, and three interdisciplinary graduate programs (Biochemistry, Molecular, Cellular & Developmental Biology, Neuroscience). Trainees enroll in 2 required courses that cover core concepts and include team based projects in CTS that emphasize research design and methodologies that are rigorous, ethical, and intentional to achieve health for all. Trainees are required to fulfill requirements of a Graduate Interdisciplinary Specialization in Biomedical Clinical Translational Science (GISBCTS) selecting from coursework in 4 tracks (Research Methods; Statistics, Data Analysis and Bioinformatics; Community and Communications, and Leadership/Team Science). Leadership and team science skill development and resiliency training at this pre-doctoral stage is expected to favorably impact the career trajectories of our trainees, increase retention of CTS investigators from all backgrounds and ultimately enhance the breadth and impact of CTS for individuals and communities. Trainees attend Lunch & Learn monthly seminars on a variety of research and career development topics facilitated by faculty and staff from across colleges. Trainees select CCTS “Tools of the Trade” in-depth workshops that focus on research topics like grant writing, community engagement, clinical trials management, and technology commercialization. Collaboration with the CCTS workforce development team, community engagement team and the K12 program permits cross-fertilization to enhance training across a spectrum of CTS researchers, expansion of trainee networks, opportunities for peer mentoring and coordinated program evaluation of learners at various career stages. The CCTS T32 Career Development Dinner Series includes informal discussion with alumni and invited guests to highlight the wide variety of research career paths and expand networking opportunities. Trainees are supported for two years of training. Six training slots per year are requested.

Public health relevance
Research today provides hope and the foundation for new treatments and cures for tomorrow. Specialized education and training in clinical and translational sciences is needed to develop investigators capable of bridging the gap between the lab, the clinic, and disciplinary boundaries and to accelerate the delivery of innovations to all communities. The goal of this new Ohio State University Center for Clinical and Translational Science predoctoral T32 training program is to leverage the large, collaborative and multidisciplinary research environment of Ohio State to recruit, train and mentor an outstanding cohort of trainees from a wide variety of graduate programs and colleges to become the next generation of clinical and translational science leaders who will lead high impact research that is rigorous, ethical and intentional to achieve health for all.